Characterizing the structure of motor cortex activity across multiple behaviors for improved brain-machine interfaces

Project Abstract. Candidate and career goals: I am an engineer by training, with a strong background in
neural engineering and the development of motor brain-machine interfaces (BMIs). My career goal is to establish
an independent nonhuman primate (NHP) laboratory with two primary aims. First, I will advance our fundamental
understanding of the motor system via the combination of electrophysiology with novel statistical and
computational methods. Second, I will leverage this knowledge to develop frameworks for superior BMI systems.
Throughout my academic and research career I have developed expertise in engineering, computation,
and neuroscience with the goal of pursuing these aims. Advances in machine learning, large-scale neural
recordings, and deep learning in neural networks are happening quickly (in part via the BRAIN Initiative), and
are very promising for the field. Yet very few researchers have the correct combination of skills to make use of
them in my areas of interest. In completing the proposed training, I will be uniquely positioned to perform the
innovative work necessary to advance our understanding of the planning and execution of cortically controlled
movements. I will train the next generation of scientists and engineers in the experimental and computational
methods necessary to understand fundamental principles of cortical computations.
Research plan: In this project, I will employ multiple computational approaches to understand the
structure of population activity in motor cortex (M1) across multiple kinds of behaviors. I will then use that
knowledge to create high performance BMI decoders that will be applicable to a wide range of movements.
Recent empirical observations are changing our view of the structure of M1 activity. During one particular
task (e.g., reaching), neural activity may seem to exist within a small space that it explores completely. Yet as
more tasks are observed, it becomes clear that activity comprises a highly structured geometry within a much
larger space. This means that activity patters for different movements do not come ‘near’ one another or overlap.
While counterintuitive, this geometry yields new opportunities. By exploiting the separation of activity patterns,
movements can be readily distinguished, even when unfolding simultaneously. I will further explore this geometry
across multiple behaviors, both in primates and neural network models, to develop new BMI methods. The
specific aims of the plan are to (1) create a high-performance decoder for a novel wheelchair-relevant navigation
task, (2) build network models to understand M1 activity structure and identify decoding principles that will
generalize across tasks (reaching, navigation), and (3) implement a multitask BMI using a unified decoder that
allows animals to both navigate and interact with objects.
Career development plan: I will be trained by Dr. Mark Churchland and Dr. Larry Abbott at Columbia University.

Public health relevance
Project Narrative Brain-machine interfaces (BMIs) interpret brain activity to control external devices (computers, prosthetic limbs), and can restore voluntary movement to individuals with limb loss or paralysis. BMIs for reaching and grasping have been demonstrated in human clinical trials, and must now be extended to perform a variety of movements. The proposed work will use advanced computational methods to create an intuitively controllable and high performance BMI system applicable to many natural movements, including locomotion. This work will both develop neurotechnology, and add to our scientific understanding of the computational principles that underlie activity in motor cortex.